Determinants of phenotypes within the word reading (dis)ability population: The impact of diverse language experiences and child attributes on emerging reading skills

This LD Hub P20 renewal entitled, “Determinants of phenotypes within the word reading (dis)ability
population: The impact of diverse language experiences and child attributes on emerging reading skills”
responds to the NICHD invitation for LD Innovation Hubs, FOA’s (RFA-HD-22-005). The overarching goal of this
LD Hub is to continue to lay the foundation for a generation of research that situates educational practices in a
novel theory of individual word reading development. The knowledge and product generated from this Hub will
be used to inform future behavioral, computational, and neurobiological studies examining the development of
word reading skills and will be used to align theories describing the relations between child- and word-attributes
that explain individual differences in word reading more closely with the educational challenges confronting
educators of typically developing (TD) and more specifically children with reading disability (RD), while also
expanding our understanding of where important differences exist in under-represented populations in RD
research. The proposal addresses the second priority of the RFA; namely “pushing innovation”, by exploring
new and complex behavioral phenotypes of RD that vary as a function of child experience and cognitive ability
across linguistically diverse samples of learners. Our LD Hub adopts an interdisciplinary approach to developing
the foundational and translational research needed to better understand the general development of item-level
word reading skill in a large portion of the English language, explore important differences in word reading
development across TD and RD populations with a focus on important historically under-represented
populations, and examine the interactions between child- and word-attributes that explain individual differences
in word reading development. The overall specific aims for the Hub include: (1) expand our understanding of
the basic mechanisms undergirding word reading development in English; (2) increase the scientific
infrastructure for research on reading disability by establishing a publicly available database
(developmental English Lexicon Project) incorporating all of the data collected in the research project;
(3) maintain and expand the Hub’s multidisciplinary team of experienced and early researchers with
expertise spanning educational, computational, and neurobiological research; and (4) strengthen the
scientific workforce by providing career enhancing opportunities for early career scientist and by
promoting its diversity through the participation of underrepresented racial and ethnic minorities, and
persons with disabilities. In achieving these aims, we will create a research team, a body of empirical
knowledge, and a theoretical framework setting the stage for (i) better educational practices, particularly related
to RD; (ii) translational research on related topics such as literacy acquisition by English Language Learners
(ELL) and speakers of dialects, and second-language acquisition; and (iii) a new generation of theories
embracing individual differences and strongly tied to the neurobiological bases of learning.

Public health relevance
Word reading disability is the most frequently diagnosed form of learning disability in children, having a major impact on health and quality of life, with effects associated with poor academic achievement, employment prospects, and problems with social relationships. Understanding complex behavioral phenotypes of RD that vary as a function of child experience and cognitive ability across linguistically diverse samples of learners who have been historically under-represented in research on specific learning disabilities is a fundamental step towards improving identification, prevention, and treatment of reading problems. The overarching goal of this LD Hub is to continue to lay the foundation for a generation of research that situates educational practices (e.g., diagnosis, curriculum, instruction, & intervention) in a novel theory of individual word reading development with the knowledge and product generated from this Hub being used to inform future behavioral, computational, and neurobiological studies examining the development of word reading skills and will be used to align theories describing the relations between child- and word-attributes that explain individual differences in word reading more closely with the educational challenges confronting educators of both typically developing (TD) and more specifically children with reading disability (RD), while also expanding our emphasis to assess where important differences exist in under-represented populations in RD research.